Ultra-low-temperature (6 K) static NMR-DNP for metalloproteins, proteins in cells, and materials

Ultra-low-temperature (6 K) static NMR-DNP for metalloproteins, proteins in cells, and materials
Abstract
The critical importance of solid-state NMR (ssNMR) was recently demonstrated by, after nearly two decades
of intense efforts, yielding the first atomic-resolution structures of the A40 and A42 amyloid fibrils that play a
crucial role in Alzheimer’s Disease (AD). Challenges posed by the inherently low sensitivity of NMR can be
improved by reducing the sample and circuit temperature to below 100 K, or preferably below 35 K – also
known as Ultra Low Temperature (ULT). Combining ULT NMR with another emerging technique, denoted as
dynamic nuclear polarization (DNP), shows enormous promise for expanding the role of ssNMR by providing
significant S/N enhancements in many cases. However, despite the huge gain in S/N that is possible from
DNP, also performed at ~90 K, there are still only a handful of high-field MAS-DNP systems in the U.S. – pri-
marily because they are so expensive ($3-10M). Further, no commercially available instrumentation is availa-
ble for NMR experiments below 90 K, let alone ULT experiments combined with DNP. A huge step forward
would include the development of a high-mode THz cavity for more efficient microwave delivery to the sample,
thus enabling the use of a lower power and lower cost microwave source. An area of ssNMR that employs the
use of non-spinning (static) samples would benefit immensely from the availability of such a commercially built
ULT probe, with option for inclusion of DNP. Further, the static probe can serve as a prototype for a MAS ver-
sion of such a probe. The developments proposed under this project aim to reduce entry level cost into DNP
by more than an order of magnitude while reducing certain operational challenges.

Public health relevance
Ultra-low-temperature (6 K) static NMR-DNP for metalloproteins, proteins in cells, and materials Narrative Thousands of researchers are regularly using Nuclear Magnetic Resonance (NMR) techniques, with most of the applications driven by the need for structure and function determination in biological macromolecules. The advances developed under this project will allow every NMR laboratory that has a wide-bore magnet to dra- matically improve their sensitivity on solids, on a budget they will be able to afford, equipping biomedical re- searchers with superb new tools for the structure-function studies of membrane proteins, cellular membrane systems, materials science, and numerous other areas.